Liberating methadone: Building a roadmap and community for change

PROJECT SUMMARY/ABSTRACT
As we continue to face the worst overdose epidemic in U.S history, urgent policy changes are needed
to expand access to evidence-based treatment to prevent overdose deaths. Methadone maintenance
treatment (MMT) is highly effective at treating opioid use disorder (OUD) and cuts overdose risk by over 50%.
And yet, MMT remains vastly under-utilized in the U.S. Since the 1970s, MMT for OUD in the U.S. can only be
accessed via daily dispensing of medication at highly structured Opioid Treatment Programs (OTPs). Rigid
regulations governing OTPs have greatly limited their availability, and have made the treatment experience
highly burdensome and stigmatizing for patients. For decades, this system has been described as a form of
“liquid handcuffs,” which degrades existing patients and deters new patients from engaging in treatment.
For the first time in 50 years, we are at a historic moment that could alter the course of MMT delivery in
the U.S.: Federal policy changes to alleviate COVID-19 risks, including increased flexibility for take-home
methadone doses, instigated discussions about needed MMT reforms, including expanding methadone
dispensing to pharmacies. However, to guide such reforms and inform a more equitable and accessible OUD
treatment system, there is a need to gather the scientific evidence, clinical expertise, and lived experience of
people receiving MMT. To this end, the NYU Grossman School of Medicine aims to host a 1.5-day conference
in July of 2023 in NYC titled “Liberating Methadone: Building a roadmap and community for change.”
This conference will provide a unique and timely opportunity to bring together key partners - including
researchers, clinicians, policy makers and people who use drugs - to discuss the past, present and future of
MMT for OUD. This hybrid in-person/virtual conference will stimulate innovative research and build cohesion
across multiple groups, setting the stage for more inclusive research collaborations and policy reforms that
meet the needs of the people most affected by the overdose crisis. Through research presentations, panel
discussions, and policy working groups, conference sessions will: (1) Discuss the first-hand experiences of
patients in the current OTP system and the need for a more accessible, equitable and person-centered
treatment system; (2) Create opportunities for innovative research and novel collaborations among diverse
partners by reviewing the existing evidence and gaps in knowledge regarding the current U.S. MMT system
and alternative methadone delivery models; and (3) Draft and disseminate research, practice and policy
recommendations to advance reforms needed to expand MMT beyond the OTP system. The conference will
support NIDA priority research areas for the application of science to advance policy, foster true community-
engaged research by bringing together a wide array of stakeholders from diverse geographies, racial and
ethnic backgrounds, and life experiences, and most importantly, promote innovation towards improving access
to life-saving and humanizing treatment and care.

Public health relevance
PROJECT NARRATIVE Methadone maintenance treatment for opioid use disorder is highly effective at reducing overdose risk, yet a rigid and outdated system of methadone regulation in the U.S. limits treatment availability and utilization. As policy makers consider methadone treatment reforms for the first time in decades, there is an opportunity to inform a more effective methadone treatment system that is based on scientific evidence, sound clinical guidance, and experiences and needs of individuals with opioid use disorder. The proposed conference “Liberating Methadone: Building a roadmap and community for change,” to be held in July 2023 in New York City, aims to bring together diverse partners - including researchers, clinicians, policy makers and people who use drugs - to stimulate innovation in research, clinical practice and policy, towards improving access to life- saving and humanizing substance use treatment and care.